Targeting a Defined Surgical Stress-Induced Inflammatory Pathway to Improve Peri-Operative Outcomes

PROJECT SUMMARY/ ABSTRACT
Despite improved intraoperative management some thoracic surgery patients suffer respiratory distress of
unknown origin after lung resection. Based on human observational studies that eosinophilia in the
perioperative period correlates with deleterious outcomes, we decided to study perioperative inflammation in a
small animal model of lung surgery. We noted that pulmonary resection results in a transient but pronounced
elevation of eosinophils in the blood and pulmonary tissue. Furthermore, we determined that global eosinophil
depletion prior to lung resection substantially improves perioperative survival, oxygenation, and ameliorates
post-operative pulmonary edema. The systemic increase in eosinophils results from their accelerated
maturation from progenitors in the bone marrow. This process of maturation is, counterintuitively, accelerated
by endogenous corticosteroids and is associated with the upregulation of specific cytokines in the bone marrow
and lung tissue. Disruption of select cytokines, such as the alarmin IL-33, or genetic deletion of defined cell
populations, such as innate lymphoid cells (ILCs), abrogates perioperative eosinophilia and improves animal
survival after major pulmonary resection. These findings led to our central hypothesis that perioperative stress
mediates endogenous steroid and cytokine-dependent eosinophil maturation and mobilization that is
deleterious to recovery partially due to production of nitric oxide. To explore this hypothesis, we propose three
Specific Aims. In Aim 1 we propose to define the mechanism/s of “stress-induced” endogenous corticosteroids
that increase maturation of eosinophils after pulmonary resection. We will specifically focus on the cytokine
environment as well as direct steroid sensitivity by eosinophils and their progenitors. In Aim 2 we will use cell-
specific conditional gene knockout strains of mice to determine the mechanism/s of eosinophil recruitment and
toxicity after pulmonary resection. We hypothesize IL-33 activates group 2 innate lymphoid cells (ILC2) which
then promote eosinophil homing and/or maturation. We will also define the role of eosinophil produced nitric
oxide in pulmonary pathology. In Aim 3 we will explore if excessive fluid administration and large ventilatory
tidal volumes increase eosinophil maturation and/or toxicity. We also plan to evaluate if disruption of eosinophil
development, by using clinically relevant protocols of IL-5 neutralization to effectively reduce their numbers,
can ameliorate deleterious effects in the perioperative period. Our data will provide novel insight into cellular
immune responses contributing to post-lung resection respiratory failure. Our data may allow for exploration of
novel therapeutic strategies or repurposing of FDA-approved drugs not currently known to improve
perioperative patient responses.

Public health relevance
Despite the increasing number of surgical pulmonary resections performed annually the effects of detrimental post-operative inflammation associated with these procedures are poorly understood. We now make a discovery that a proinflammatory cell population, known as the eosinophil, is detrimental to recovery post-lung resection in a translational animal model. Here we explore the physiology of this cell population in a small animal model with the hope of improving both long and short-term post-operative outcomes.